Protective and Pathogenic T Cells Responding to SARS-CoV-2 in Health and Disease

SUMMARY
Understanding the adaptive response to SARS-CoV-2 is critical to halting the devastation wreaked by the
COVID-19 pandemic, by identifying new drug targets and informing the rational design of vaccines. Common
coronaviruses and human rhinovirus (RV) both cause common cold, and multiple strains of each exist that
have varying degrees of sequence identity. All humans, and adults in particular, possess antigen-experienced
immune cells by virtue of frequent viral infections. Our work using experimental infections with RV in man has
provided unprecedented insight into adaptive immunity to this relatively benign, but troublesome, virus.
Seminal findings include a pivotal role for the rapid mobilization of cross-reactive memory T helper 1 (Th1)
cells and T-bet+ B cells in controlling RV infection. Th1 cells are critical to anti-viral responses by aiding in viral
clearance through secretion of IFN-γ, and providing help to B cells for the production of neutralizing antibodies.
Notably, expansion of circulating RV-specific Th1 cells is limited to those infected patients who develop serum
neutralizing antibodies, whereas this feature is lacking in those who are infected but fail to mount an antibody
response. Nonetheless, there is also evidence of a pathogenic role for virus-specific Th1 cells in patients with
asthma who are at risk of adverse sequelae, based on enhanced and persistent responses. We posit that a
similar scenario underlies the “cytokine storm” and rapid decline in patients with severe COVID-19 and those
who are at risk, thereby reflecting the double-edged sword of Th1 cells in anti-viral immunity. The technological
tools and analytical pipelines developed to study cross-strain immunity to RV infections, coupled with access to
COVID-19 patients and those at risk, allow us to pivot quickly to analyze T cell responses to SARS-CoV-2.
Powerful single-cell analytical tools for interrogating large cell numbers will be used to test the theory that
cross-reactive T cells respond rapidly to SARS-CoV-2, and their numbers and functional attributes determine
disease status in healthy individuals and at-risk patients. Based on our expertise, we are uniquely poised to
map CD4+ T cell epitopes across the SARS-CoV-2 proteome. These data will be used to generate
MHCII/peptide tetramers to detect and phenotype cross-reactive SARS-CoV-2-specific memory CD4+ T cells
that pre-exist in uninfected adults and persist in recovered COVID-19 patients. This will establish proof-of-
concept for priming of T cells for rapid response by previous exposures to related coronavirus strains (Aim 1).
Next, novel computational tools and tetramers will be used to identify hallmarks of overactive virus-specific T
cells in hospitalized COVID-19 patients in the acute phase, and to assess immune paralysis and antibody
deficiencies in those who develop respiratory failure (Aim 2). Finally, we will confirm in vivo expansion of virus-
specific pathogenic Th1 cells in uninfected asthmatics with severe disease, and boosting of their function by
pro-inflammatory cues present in the lower airways (Aim 3). Study outcomes will yield new insight into T cell
mechanisms of viral pathogenesis, and aid in vaccine design and monitoring for COVID-19.

Public health relevance
NARRATIVE The devastation caused by SARS-CoV-2 and COVID-19 highlights a dire need to expedite knowledge on the adaptive response to SARS-CoV-2, in order to understand risk factors for infection and re-infection, to identify new treatment targets, and aid in vaccine design. This project leverages powerful single-cell analytical methods for studying respiratory viruses in man, in order to analyze T cell responses to SARS-CoV-2 in healthy subjects, those who develop severe COVID-19, and asthmatics who are at risk. The multi-faceted outcomes will provide valuable scientific tools specific to SARS-CoV-2, identify protective and pathogenic biomarkers, and help to inform treatments and vaccines to mitigate this deadly virus.